NICHD maternal fetal medicine units network

ABSTRACT
This proposal describes the team, environment, and resources of The Ohio State University (OSU) Center that
allow it to substantively and meaningfully participate in, and meet the objectives of, the Eunice Kennedy Shriver
NICHD Maternal Fetal Medicine Units (MFMU) Network. The OSU Center has demonstrated strong performance
and experience in conducting clinical and translational research due to its scientific expertise, excellent
infrastructure, and institutional support. The research team for this proposal is led by Maged Costantine, MD,
who serves as Division Director for Maternal-Fetal Medicine and PI for the MFMU Network Center, and William
Grobman, MD, MBA, who serves as Vice-Chair for the Department of OB/GYN and Alternate PI for the MFMU
Network Center. In addition to their productivity within the MFMU Network, both the PI and Alternate PI bring
extensive experience in study design, recruitment, data analysis, and dissemination of results. Their research
foci on disparities in obstetric care and outcomes, perinatal pharmacology, epidemiology, clinical trial design,
and translational research is complementary and will be an asset to the Network. The OSU Center will recruit
study participants from racially and ethnically diverse populations at 2 medical centers with a combined total of
more than 10,000 annual births, many of which are to high-risk individuals who receive prenatal care within the
two systems. Our Center’s Nurse Coordinator, Anna Bartholomew, MPH, RN, BSN, CCRP, leads a large group
of research staff capable of recruiting and retaining patients in the setting of a research organization that has 32
of years of experience in the MFMU Network; demonstrable experience in multiple other cooperative research
settings, including the NICHD nuMoM2b Network, NICHD Maternal and Pediatric Precision in Therapeutics
(MPRINT), NIH Helping to End Addiction Long-term (HEAL), and the NIH Researching COVID to Enhance
Recovery (RECOVER) Initiative; and engagement with other multi-site initiatives such as the North American
Fetal Treatment Network, Ohio Better Birth Outcomes, and Ohio Perinatal Research Network. We additionally
benefit from a robust bioinformatics structure and versatile Electronic Medical Record System that captures
antepartum, intrapartum, and postpartum data and is readily available to authorized research personnel for data
query and notification of research subjects’ eligibility; an extraordinary group of obstetrical sonographers and
perinatal epidemiologists; and a mature research infrastructure supported by a CTSA grant shared with
Nationwide Children’s Hospital. Our satellite site, Miami Valley Hospital in Dayton, has an outstanding record of
recruitment in the prior Network cycles, well-established research culture, and ambitious goals for MFMU
Network participation. Our strong clinical and research collaboration with OSU neonatology [including in the
Neonatal Research Network (NRN)], anesthesiology, pathology, the clinical laboratory, and pharmacology add
strengths to our application. We look forward to continuing our tradition of service, strong performance, and
innovation in the renewed NICHD MFMU Network, and accept the RFA’s capitation and participatory stipulations.

Public health relevance
PROJECT NARRATIVE The NICHD MFMU Network is the premier obstetric research network in the world. Clinical investigations of the causes of maternal, perinatal, and infant mortality and morbidity and their ultimate prevention require large and diverse numbers of participants who are recruited from multiple collaborating centers. The Ohio State University Center has been a leading member of the MFMU Network since 1992 and has an energized research team committed to building upon our tradition of excellence in order to achieve the goals of the Network in conducting clinical trials and observational studies in a collaborative approach across all Network centers.